Bivalent degraders of the understudied transcription factor TBXT for the rare cancer chordoma

Project Summary / Abstract
Chordoma is a rare bone cancer with an incidence of about 1 in a million people. The tumors can appear
anywhere along the spine, from the tailbone to the skull base. The only available treatments are radiation and
surgery, and surgery can be complicated due to adjacency to important and sensitive areas like the brain and
spinal cord. No medicines are approved for the treatment of chordoma and, as such, identification of druggable
targets is a critical unmet need. The understudied protein brachyury, gene name TBXT, is upregulated in
chordoma and is both a key driver and potential therapeutic vulnerability of chordoma. Brachyury is expressed
at very low levels or not at all in most human tissues, providing confidence that compounds that modulate
brachyury will safely target the cancer and have an excellent therapeutic window in humans. Brachyury
(TBXT) is a transcription factor, a class of proteins often considered undruggable. We have recently identified
small molecule ligands that bind to brachyury, paving the way for a new approach to target this protein using
bivalent degrader molecules. Bivalent degraders, often called proteolysis targeting chimeras (PROTACs)
harness the power of the ubiquitin-proteasome system to label proteins for degradation and this leads to their
removal. In this pilot project, we will convert our small molecule brachyury ligands into a library of PROTAC
reagents and evaluate their ability to degrade brachyury in chordoma cell lines. To improve our chances of
successful degradation we will vary the brachyury ligand, the linker, and the E3 ligase targeting moiety.
Successful completion of this project will establish the understudied protein brachyury as a druggable target for
chordoma and set the stage for larger projects designed to identify PROTACs that can be used to treat this
devastating rare cancer.

Public health relevance
Project Narrative Brachyury, a transcription factor encoded by the gene TBXT, is a developmental protein that is typically not present in most cells and tissues of healthy individuals but is overexpressed in the rare cancer chordoma. Evidence suggests that brachyury represents a key vulnerability of chordoma and is a promising target for developing a treatment for chordoma. We have identified small molecules that bind to brachyury and in this project we will convert these molecules into compounds that eliminate brachyury from cancer cells by taking advantage of recent progress in the field of bivalent degraders, commonly known as PROTACs (proteolysis targeting chimeras).